Targeting Adipocyte Lipases to Treat Pancreatic Cancer-Associated Cachexia

DESCRIPTION (provided by applicant): Cachexia is a progressive atrophy of adipose tissue and skeletal muscle that occurs in more than 85% of pancreatic ductal adenocarcinoma (PDAC) patients. It is a major contributor to the mortality of patients and an independent predictor of shorter survival. Cachexia dramatically reduces the quality of life of PDAC patients and increases the risk of treatment failure and toxicity. Treatments against cachexia are palliative in nature: there is no effective therapy for cancer-associated cachexia. Recently, increased interest has focused on tackling cachexia by attempting to revert the metabolic alterations that are associated with cachexia. A key feature in cancer cachexia is the loss of adipose tissue. Studies in humans have shown that increased adipocyte lipolysis, not reduced lipogenesis or increased fat cell death, is the primary cause of fat loss in cancer cachexia. Treating cancer patients with agents that address the adipocyte dysfunction that is the basis of the cachexia, in combination with standard antineoplastic agents, may dramatically enhance their quality of life and the chances of success of the anti-tumor treatment. All enzymes known to be involved in adipocyte lipolysis (ATGL, HSL, MGLL) are serine hydrolases. Genetic ablation of adipose triglyceride lipase (ATGL) and to a lesser extent hormone sensitive lipase (HSL) can protect from cancer-associated cachexia, demonstrating that correction of the adipocyte dysfunction is indeed a viable approach to reverse cancer-associated cachexia. However, systemic inhibition of these serine hydrolases is predicted to have deleterious effects that preclude this approach to treat cachexia. For example, ATGL null mice accumulate lipid in the heart and die prematurely. Integrating phenotypic screening with chemoproteomic methods, we recently identified another serine hydrolase, Ces3, which regulates adipocyte lipolysis. Pharmacologic inhibition of Ces3 ameliorates multiple features type 2 diabetes (another condition that involves increased rate of adipocyte lipolysis) without inducing side effects. We intend to evaluate the therapeutic potential of Ces3 inhibition in pancreatic cancer-associated cachexia, and to identify additional poorly annotated serine hydrolases that may serve as targets in cancer-associated cachexia.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cachexia is a profound loss of adipose tissue and muscle mass that dramatically reduces the quality of life of pancreatic cancer patients and their survival time. This project will test the extent to which drugs that block the release of lipids from fat cels can reverse the pancreatic cancer cachexia. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Pancreatic adenocarcinoma has a dismal prognosis: less than 5% of patients diagnosed with the disease are alive five years later.1 Pancreatic ductal adenocarcinoma (PDAC, accounting for 95% of all exocrine pancreatic malignancies) has such a poor prognosis because as a rule the disease only becomes apparent at late stages, and because it resists all forms of conventional therapy. In addition, more than 85% of pancreatic cancer patients develop cachexia, or wasting. Cancer-Associated Cachexia (CAC) is a pathological state that occurs in more that 50% of cancer patients and consists of a progressive atrophy of adipose tissue and skeletal muscle.2 CAC is a major contributor to the mortality of cancer patients and it is an established, independent predictor of survival: the greater the weight loss, the shorter the survival time. In pancreatic cancer, 85% of patients show an average weight loss of 14.2% at the time of diagnosis.2 Cachexia dramatically reduces the quality of life of PDAC patients and increases the risk of treatment failure and toxicity. Treatment options for cachexia are palliative: there is no effective treatment for CAC.3 A key feature in cancer cachexia is the loss of white adipose tissue. Studies in humans have shown that increased adipocyte lipolysis, not reduced lipogenesis or increased fat cell death, is the primary cause of fat loss in cancer cachexia.4 Lipolysis is the process whereby the adipocyte hydrolyzes stored triglycerides into free fatty acids and glycerol to be used as fuel by other tissues at times of need. Adipocyte lipolysis is primarily regulated by catecholamines, insulin, and natriuretic peptides, though factors induced in disease can also modulate lipolysis (e.g., inflammatory cytokines such as TNF-α).5 All enzymes known to be involved in adipocyte lipolysis (ATGL, HSL, MGLL) belong to the serine hydrolase family.6 It was recently shown that genetic ablation of adipose triglyceride lipase (ATGL) and to a lesser extent hormone sensitive lipase (HSL) can protect from cancer-associated cachexia.7 However, systemic inhibition of these serine hydrolases is predicted to have deleterious effects that may preclude the use of inhibitors for treating CAC. For example, ATGL null mice accumulate lipid in the heart and die prematurely.8 Using a combination of phenotypic screening and chemoproteomic methods, we recently isolated serine hydrolase-directed small-molecule compounds that enhance adipocyte differentiation and lipid accumulation and identified their molecular targets. One of these pro-adipogenic compounds that enhance lipid storage inhibits the serine hydrolase Ces3 (TGH), an endoplasmic reticulum lipase.9 Administration of a Ces3 inhibitor to high-fat fed or obese-diabetic db/db mice improved blood lipid levels (e.g., reduced FFAs, triglycerides) and increased insulin sensitivity and glucose tolerance. The mechanism of action of the Ces3 inhibitor is based on suppression of adipocyte lipolysis. Recently described Ces3 null mice also have decreased plasma lipids and improved glucose tolerance, but unlike ATGL or HSL null mice, they are completely healthy.10 Our findings (manuscript in revision) indicate that inhibition of Ces3 (and thus inhibition of adipocyte lipolysis) may be of therapeutic benefit for cancer cachexia. They also illustrate the advantage of using an integrated approach to identify poorly annotated adipocyte serine hydrolases (more than 50% have no ascribed function) that may be involved in lipolysis, and thus may represent new targets for cancer-associated cachexia. Our hypothesis is that Ces3 inhibitors will be useful for the treatment of pancreatic cancer cachexia. We will test this notion and also identify additional serine hydrolases that serve as therapeutic targets for cancer cachexia. Our aims are: Specific Aim 1: Evaluate the therapeutic potential of Ces3 inhibition in cancer-associated cachexia. Mice bearing tumors derived from pancreatic cancer cell lines known to induce cachexia will be treated with a Ces3 inhibitor. Efficacy of the Ces3 inhibitor in CAC will be assessed using a variety of parameters to evaluate adipose tissue health (WAT mass, body weight composition, plasma biochemical and inflammatory profile, lipolysis rate in WAT explants) and skeletal muscle degeneration (e.g., proteasome and caspase activity). Specific Aim 2: Identify unannotated serine hydrolases that modulate adipocyte lipolysis and pharmacologic tools to assess their utility in pancreatic cancer cachexia. A library of serine hydrolase- directed, traceable chemical probes will be screened in a cell-based assay to isolate compounds that regulate adipocyte lipolysis. Chemoproteomic methods will be used to identify the molecular targets of compounds that regulate fat cell lipolysis. Compounds that modulate lipolysis by inhibiting uncharacterized serine hydrolases will be optimized for selectivity and potency and their in vivo efficacy in pancreatic cancer cachexia tested. This work will assess the effectiveness of serine hydrolase inhibitors that modulate adipocyte lipolysis (e.g., Ces3) in pancreatic cancer-associated cachexia, a major unmet medical need. These tools will also be useful to test the utility of inhibiting adipose tissue lipolysis in cachexia induced by other tumors, as wells as in other forms of cachexia, such as HIV-induced cachexia.